Leadless wirelessly powered pacemaker for multi chamber pacing using miniaturized pacing and sensing node

Project Summary
Cardiovascular diseases claim more than 17 million lives worldwide every year. In the United States alone, 92.1
million people are affected by cardiovascular disease, and 32% of all major deaths are attributed to it. A portion
of the cardiovascular disease population has abnormalities that necessitate implantation of a pacemaker to
maintain normal heart rhythm. A pacemaker is a device that sends regular electrical impulses to the heart via
long wires called leads connected to a generator placed underneath the skin. In the United States alone,
pacemakers are implanted in more than 370,000 patients annually. Complications related to pacemaker
implantation occur in 10% of these patients. These complications are largely device-related and include lead
failure, lead dislodgement, infection, tricuspid regurgitation, and venous occlusion. Recent developments in
pacemaker technology have led to leadless pacemakers, which have shrunk the pacemaker into a bullet-sized
device that can be implanted inside the heart. However, these devices in their current form factor are too bulky
to provide therapy to pediatric patients. To address this problem, we developed a miniature (11 mm × 11 mm),
leadless, wirelessly powered pacing device that can pace multiple locations across the heart synchronously. Our
successful experiments in pacing multiple chambers of the heart in vivo has led to the hypothesis that this
approach of multisite pacing will our technology will enable the development of miniature devices that will provide
leadless, wirelessly powered means of pacing at unprecedented numbers of sites and in previously inaccessible
regions, thereby enhancing myocardial synchronization and conduction. In this proposal, we aim to develop a
system comprising of a distributed network of wirelessly powered pacing and sensing nodes (SA 1) that can be
controlled by a data-driven algorithm (SA 2) to provide optimal cardiac resynchronization therapy. This system
will be iteratively developed and validated in a subacute in vivo porcine model of heart failure (SA 3). Drs.
Babakhani, Cavallaro, and Lin will each contribute to the hardware development. Dr. Aazhang will supervise the
development of the data-driven algorithm, and Dr. Razavi will oversee device development and all animal
studies. Research outcomes from this project will improve our understanding of wireless power transfer, lead to
the creation of novel intracorporeal inter-device communication protocols, and offer an innovative approach to
pacing therapies. The device in its refined state will be small enough for transvenous delivery, capable of
synchronous pacing and sensing from multiple locations, and deliver appropriate personalized therapy by using
algorithms to detect patient-specific rhythm abnormalities. Such a device will have far-reaching clinical impact
by allowing pacing at multiple locations, including those that were previously inaccessible. Furthermore, the
device will normalize conduction across a damaged heart to better manage arrhythmia and can provide
imperceptible low-energy defibrillation for painless cardioversion.

Public health relevance
PROJECT NARRATIVE Conventional pacemakers have two major pitfalls: 1) wires that run through the venous system and into the heart, called leads, which are prone to complications such as lead fracture, lead dislodgment, and lead migration, and 2) bulky size, which limits pacemakers’ use to single-chamber pacing. Current disruptive pacemaker technologies focus on the development of leadless systems, which remove the need for risk-prone leads, and of miniature, battery-less devices. Thus far, no systems exist that effectively combine both features. We have developed a novel pacemaker system that is both leadless and wirelessly powered, which allows simultaneous pacing and sensing from multiple sites in the heart. This design has the potential to reduce traditional pacemaker- related complications and improve the function and applicability of these devices to populations in need.